Data Science Core for Biomedical Research

Data Science Core for Biomedical Research - Abstract
The NV INBRE Data Science Core for Biomedical Research is a biomedical research resource hub for all
statewide researchers at any level including undergraduates. The goals of core include 1) support the
generation and analysis of new omics datasets with a focus on Cell Growth and Differentiation; 2) train the next
generation of researchers in bioinformatics and data science; 3) build upon the existing research infrastructure
within Nevada and across the Mountain West by creating new partnerships; 4) strengthen the Nevada
research network by collaborating with other IDeA programs such as COBREs and the MW CTR-IN; 5) provide
resources for big data sharing and cloud computing; 6) support new research endeavors, manuscript
preparation, and grant proposals; 7) assist in new scientific services such as neuroimaging analysis, single-cell
sequencing, advance proteomics analyses, and machine learning applications; 8) coordinate outreach events
with all partner institutions; 9) support undergraduate research efforts, and 10) support K12 STEM education.
These goals will be accomplished by closely working with the Administrative Core, leveraging five NV INBRE-
supported core facilities, and collaborating with faculty at all partner institutions. The core will assemble a
statewide steering committee to oversee the core’s activities, and provide recommendations for overall
priorities and new efforts.